Cryptic bacterial carrier proteins bridging fatty acid synthase

Project Summary. Until recently, sphingolipids within the microbial environment have been attributed to host
association, as the conventional wisdom was that bacteria did not contain their own biosynthetic pathways to
produce them. Recently, members of our team uncovered a new bacterial sphingolipid pathway involving an acyl
carrier protein similar to that of fatty acid synthase (FAS). This new acyl carrier protein, AcpSP, appears to play
a role distinct from its FAS progenitor, AcpP, whose primary purpose lies in de novo fatty acid synthesis.
Remarkably, AcpSP shares less than 30% sequence identity to AcpP, suggesting a unique activity and
interaction landscape than that of AcpP. We have identified AcpSP and serine palmitoyltransferase (SPT) within
in many pathogenic bacteria, including Neisseria gonorrhoeae, Escherichia coli (studied herein), Staphylococcus
aureus, Listeria monocytogenes, Salmonella typhimurium and Pseudomonas aeruginosa, indicating that this
pathway may be involved in pathogenesis. In this program, our team applies a suite of chemical and structural
biology tools originally developed for the study of AcpP in order to explore the interaction of AcpSP with its
partner enzymes. Using a combination of chemical probes and structure-based methods, we will characterize
the interface between AcpSP and SPT, the first key step in sphingolipid biosynthesis. To further explore the
cryptic interactions between sphingolipid biosynthesis and FAS, we will deploy a systems-wide structural
analysis to detail AcpSP interactions with de novo FAS enzymes. This program provides an essential step toward
understanding bacterial sphingolipid biosynthesis and its role in pathogenesis and will likely provide important
new targets for future drug discovery.

Public health relevance
Project Narrative. This program provides new insight into a recently discovered primary metabolic pathway in bacteria, sphingolipid biosynthesis, which appears to bridge fatty acid biosynthesis in pathogenic bacterial species. Structural data developed from this program will provide critically needed information to understand the mode and mechanisms of protein • protein interactivity that enable the progression of this pathway in pathogenic bacteria. While bacterial fatty acid biosynthesis is a validated antibiotic drug target, this discovery and data obtained from this program will serve as a critical next step towards understanding the fundamentals of associated lipid metabolism within bacterial pathogenesis.